Stanford ChEM-H Chemistry/Biology Interface Predoctoral Training Program

Project Summary/Abstract
This application seeks funding for 10 trainees within the ChEM-H Chemistry-Biology Interface (CBI) predoctoral
training program at Stanford University, aligned with the mission of the Stanford ChEM-H institute. Stanford
ChEM-H was formed with the mission of bringing chemists, biologists, engineers and clinicians together to
pursue a molecular level understanding of the principles underlying human health and to devise innovative
disease interventions. The program’s primary mission is to cultivate interactions, thinking, and communication
across the chemistry biology interface to enable innovations in the study and advancement of human health.
The CBI Training Program will provide PhD students with a diverse community of peers and mentors from the
Schools of Humanities and Sciences, Engineering, and Medicine. Graduate students in the program will be
recruited from six PhD granting programs: Chemistry, Chemical Engineering, Chemical & Systems Biology,
Biochemistry, Biology and Bioengineering. Appointed trainees are supported by the CBI Training Program for 2
years, usually the second- and third-year of graduate study. Mentors are affiliated with diverse departments and
programs, including practicing physician scientists. Key components of the program are inclusion of students
during the first year of graduate study, first-year laboratory rotations, coursework in chemical biology, instruction
in the responsible conduct of research and enhancing reproducibility, student and faculty seminars, and career
development activities. Professional development activities include a career panel, conference presentations,
communication training for outreach, and an annual retreat. Students will also receive instruction on developing
strategies to translate molecular findings to humans. The Training Program aims to increase trainee diversity
within Stanford ChEM-H by maintaining 40% URM of trainee cohorts, building an inclusive community through
mentor training, and retaining graduates in PhD programs and within the biomedical research workforce.
Anticipated trainee outcomes are peer-reviewed publications at the chemistry biology interface, conference
presentations, receipt of external funding, and retention within the biomedical research workforce in a variety of
academic and non-academic positions. Students trained in this program will be exposed to a wide range of
scientific concepts and techniques, meet diverse experts across the physical, life and medical sciences, and be
uniquely situated to tackle challenges in human health from a molecular level perspective.

Public health relevance
Project Narrative This program trains students to address challenges in human health by applying the foundations of biology to life at a chemical and molecular level. The program brings together chemists, biologists, engineers, and physician-scientists to foster creative thinking across disciplinary lines, leading to the discovery and engineering of molecules, materials and measurement tools that advance human health. Students trained in this program will be primed to revolutionize the way medicines and medical treatments are conceived, created, and implemented.